Dissemination of an Adolescent Obesity Prevention Intervention to Louisiana Schools

Abstract
The goal of this R15 project is to disseminate the evidence-based SWITCH–MS intervention to Louisiana. The
re-branded Louisiana-based Preventing Obesity Using Digital-assisted Movement and Eating (ProudMe) will
retain the effective, school-based components of the SWITCH–MS but will also receive theory-informed, novel
adaptations to integrate technology-based components tailored for the more racially diverse populations in
Louisiana. We will enlist the aid of multiple trained student researchers to address two aims. In Aim 1, we will
recruit 480 adolescents (11-13 years old in 6th-7th grades) from 48 classes across 12 schools (cluster-
randomized to 6 ProudMe schools vs 6 wait-list control schools), to determine the effectiveness of the
ProudMe intervention on obesity-prevention behaviors and weight status. In Aim 2, we will collect mixed-
methods data from 24 school implementers (i.e., teachers, administrators, and staff), 96 adolescents, and 96
parents at the 6 ProudMe schools in early, mid, and late phases of the intervention, to capture adaptation and
implementation indicators. Building on our previously funded works (e.g., R21HD090513, PI: Dr. Chen), this
project will be led by a strong, collaborative, transdisciplinary team with experts from kinesiology,
developmental psychology, nutrition, childhood obesity, computer science, statistics, and implementation
science. Our team has developed the ProudMe prototype and is ready to beta test and then deploy the
intervention for this proposed project. The advent of the project will significantly strengthen the research
environment of the Louisiana State University (LSU) – a primarily undergraduate student serving institution
under-funded by the NIH. The project is in line with the new LSU president’s vision of “scholarship first”, as it
will create unique, practical research opportunities that are otherwise unavailable for LSU students who aspire
to seek advanced education or careers in biomedical and health fields. We expect the ProudMe intervention to
demonstrate sound effectiveness and implementation outcomes, adding new insights to the Dissemination and
Implementation (D & I) research on adolescent obesity prevention. The intervention will directly benefit
hundreds of Louisiana adolescents and their families and schools for obesity prevention. The findings will lead
to our future R01 applications and broader dissemination of the ProudMe intervention.

Public health relevance
Narrative This R15 project will provide training opportunities for undergraduate and graduate students to disseminate the novel ProudMe (Preventing Obesity Using Digital-assisted Movement and Eating) intervention in Louisiana schools. Aim 1 will use a cluster-randomized controlled trial to determine effectiveness of the ProudMe intervention at improving adolescents’ obesity-prevention behaviors and weight status, while Aim 2 will collect mixed-methods data from school administrators, teachers, parents, and adolescents to capture implementation. The project will significantly strengthen the research environment of LSU, create unique opportunities for LSU student researchers to prepare for biomedical and health fields, advance current knowledge about adolescent obesity prevention, directly benefit hundreds of Louisiana adolescents and their families and schools, and lead to broader dissemination of the ProudMe intervention.